Factors in Persistence Versus Fadeout of Early Childhood Intervention Impacts

PROJECT SUMMARY
An urgent child policy question facing the U.S. concerns how much and in what way to invest in
early care and education, particularly pre-kindergarten (pre-k). Rigorous evaluations of pre-k
programs within states have produced positive, negative, and null findings that are difficult to
reconcile, necessitating an approach that can integrate data across time and contexts. We ask
whether variations in investments by the 50 states across the past 20 years are associated with
better child health, achievement, and family outcomes. Our study will build on our previous
work in North Carolina (NC), which examined the effect of variation in pre-k funding to counties
across years on child outcomes using econometric analyses of panel data. Our first aim is to
evaluate whether the beneficial impacts of investments in public pre-k generalize
across the nation and with other estimation approaches. We will use this rigorous
method at the national level by compiling the first state-by-year-level dataset that integrates
pre-k funding, pre-k program features, state characteristics, and child and family outcomes (e.g.,
NAEP scores, anxiety, disability, maternal employment), applying a state- and year-fixed effects
approach. We also incorporate new NC data for an instrumental variables approach, using the
interaction between a family's proximity to the nearest NC Pre-K center and funding for pre-k as
an instrument for pre-k attendance—providing innovative causally-informative evidence of pre-
k effects. The second aim is to determine whether statewide investments in pre-k
promote equity in children's well-being across race, ethnic, and income groups. In
our nationwide study, we will test whether state investment levels have differential impact on
subgroups of children, and in NC, we will test whether our new analytic approaches demonstrate
equity-enhancing impacts on child achievement. The third aim is to examine whether
features of state pre-k programs and children's environments are associated with
differential impact of states' investments, which we test through moderation analyses of
carefully collected pre-k implementation data in each state and year. The fourth aim is to
examine whether prior NC Pre-K exposure protected children from the adverse
impact of COVID-19, by contrasting academic achievement for NC Pre-K attenders with a
matched group of non-attenders during pre- and post-COVID periods, as well as moderation of
hypothesized protective effects by schools' pandemic instructional policies (i.e., remote, hybrid).
Together, this work will inform child development theory about the enduring impact of early
education experiences and optimal policy strategies for promoting equitable learning outcomes.

Public health relevance
PROJECT NARRATIVE Early childhood education programs can influence a host of developmental outcomes through their provision of stimulating learning spaces, nutritious meals, screening for vision, hearing, health, and developmental difficulties, and by providing safe and reliable childcare that enables parents to work or further their education. However, most pre-kindergarten evaluation studies examine academic achievement outcomes alone, leaving a large gap in our understanding of how early learning interventions affect child health and family well-being. We will be the first to evaluate the impact of state pre-k investments over the past 20 years on a comprehensive set of child and family outcomes, including child physical and mental health, and maternal mental health and employment, to test whether pre-kindergarten investments have broad impact and to determine the pathways through which children develop.